Preventing the Hypoxia-Adenosinergic Inhibtion of Anti-HIV Immune Response

It is believed that innovative adjuvants might be capable of inducing higher titers of broadly neutralizing anti-HIV-1 antibodies and better anti-HIV-1 T-cell responses. We propose to explore a novel opportunity to improve the effectiveness of anti-HIV vaccines by using anti-adenosinergic

Public health relevance
Of Public Health importance, translating this novel HIV vaccination strategy into human trials can be accelerated since the co-adjuvants to be tested are drugs that are readily available and safe. Of relevance to the AIDS epidemic, even caffeine, the inexpensive natural A2AR antagonist, substantially enhanced the vaccination-induced anti-HIV IgGI, lgG2a and IgM levels if combined with otherwise weak adjuvants.